SPECTRAL ANALYSIS OF THE EFFECTS OF CALCIUM ION ON ALPHA CRYSTALLIN CONFORMATION

The long-term objective of this project is to determine the effects of the presence of calcium ion on the configuration of the ocular lens protein alpha-crystallin. Ocular lens transparency depends on the specific packing of proteins that are synthesized. It has been shown that a-crystallin, a major protein component of the ocular lens, plays an important role in maintaining the transparency of the lens. It prevents heat-induced and photo-aggregation of other crystallins and enzymes by acting like a molecular chaperone. The chaperone-like activity of a-crystallin is believed due to the protein providing properly placed hydrophobic surfaces upon which the damaged protein interacts. It is thought that this chaperone-like behavior may be important in preventing cataract formation. Since it has been discovered that a-crystallin acts as a molecular chaperone under various denaturing conditions, research has focused on determining this mechanism of action that is thought to be protein conformation dependent. It is of interest to determine conditions which bring about this reduction in the chaperone ability of a-crystallin. It is hypothesized that acrystallin's configuration, and thus its chaperone-like behavior, is affected when its configuration is altered under stress conditions such as exposure to near-UV radiation. This proposal (prepared in collaboration with Dr. Lisa Hibbard (Spelman College) sets forth studies to investigate the effects of solvent ionic strength on the configuration and chaperone-like activity of a-crystallin and the lens structural protein, b-crystallin. Since it has been recently proposed that calcium binding may have either a deleterious or pivotal role in the chaperone-like behavior of a-crystallin depending on the concentration of ion present, ionic strength studies are relevant as it is known that the concentration of certain ions, in particular Na+ and Ca2+, can vary under given conditions in the ocular lens, particularly those in which cataracts are present. The combination of increased solvent ionic strength and exposure of aqueous solutions of a-crystallin to UV-A radiation will also be studied. It is of interest to determine whether the varying solvent conditions and exposure to UV radiation affects the ability of a-crystallin to protect b-crystallin upon heating. The project will study the effects of calcium ion on native and damaged protein conformation using both FTIR (and deconvoluted peak data) and far-UV CD spectra (done at Spelman College).